Motor Skill and the Cortical Motor Areas

PROJECT SUMMARY
The acquisition and retention of skilled sequential movements is a fundamental part of human behavior.
We still know little about where and when plastic changes occur in the cortical motor areas to learn and
maintain skilled sequential movements. Here, we propose to study the temporal evolution of the learning and
maintenance of skilled sequential movements in primary motor cortex (M1) and dorsal premotor cortex (PMd)
by pharmacologically manipulating information storage in these areas.
We will train monkeys to perform two tasks. In one task, the monkeys perform sequential reaching
movements guided by memory. Skill on the memory-guided sequential movements task is acquired through
considerable practice. For a control task, the monkeys perform reaching movements guided by visual cues.
Our preliminary data showed that an injection of an inhibitor for protein synthesis or an inhibitor for DNA
methylation into M1 of monkeys disrupted the performance of acquired sequential movements without affecting
the performance of visually guided reaching. We will apply these approaches to examine the nature and time
course of plasticity processes in M1 and PMd that support the learning and maintenance of extensively
practiced motor skills. First, to determine whether the neural trace for sequential movements is gradually
consolidated in M1 with extended practice, we will inject an inhibitor of protein synthesis into M1 at multiple
time points during learning of sequential movements. We hypothesize that the motor skill is repetitively
consolidated through protein synthesis every time a subject practice, and that the rate of consolidation declines
as learning proceeds. Second, to determine when PMd is involved in learning the associations between
movement elements in a sequence, we will inject an inhibitor of protein synthesis into PMd at multiple time
points during learning of sequential movements. We hypothesize that learning processes in M1 and PMd
operate in different time frames. Third, to determine whether M1 and PMd become sites of long-term storage
for the acquired sequential movements and remain critical for the maintenance of the acquired sequential
movements, we will inject an inhibitor of DNA methylation into these areas. We postulate that the injection will
disrupt the maintenance of memory-guided sequential movements after long term practice and that the
monkey will need to relearn the sequence to recover his performance after the injection.
Completion of the proposed studies will expand our understanding of the temporal evolution of the
learning, as animals slowly become highly skilled with ongoing long-term practice and consolidation. That level
of motor sequence expertise is never studied in rodents and rarely in monkeys, yet it is a common feature of
everyday human motor performance. The results will provide information to develop new strategies for
acquiring motor skills and enhance functional recovery following stroke or traumatic brain injury.

Public health relevance
PROJECT NARRATIVE To study where and when plastic changes occur in the cortical motor areas to acquire and retain skilled sequential movements, we propose to manipulate information storage in primary motor cortex (M1) and dorsal premotor cortex (PMd) of non-human primates by injecting inhibitor for protein synthesis or DNA methylation into these areas. We will examine whether the neural trace for sequential movements is gradually consolidated in M1 with extended practice, whether learning processes in M1 and PMd operate in different time frames, and whether M1 and PMd become sites of long-term storage for the acquired sequential movements. The results will expand our understanding of the temporal evolution of the learning and provide information to develop new strategies for acquiring motor skills.